Unraveling the molecular connections that link circadian rhythms and lipid metabolism

SUMMARY: This Administrative Supplement requests support for Brooklyn Messenger, an
undergraduate student to gain summer research experience. Brooklyn is considering pursuing a
health-related science career. She has had some opportunities to shadow and explore the
medical field but none with research. As a student athlete, she does not have as many
opportunities with research during the school year. In the summer, she will conduct
experiments in a project to probe the molecular interconnections between the molecular clock
and lipid metabolism. She will learn the process of proposing a specific scientific hypothesis,
designing experiments to test it, interpreting data, and making scientific presentation. These
activities in gaining research experience in a cutting-edge scientific environment will enhance
her understanding of scientific research and help Brooklyn determine her future career
pursuits.

Public health relevance
NARRATIVE: This supplement requests for support of an undergraduate student who is considering a health-related career by providing authentic research experiences during the summer. The student will take part of the study to elucidate biochemical and molecular interplays between the circadian clock and lipid metabolism.